Avoiding Adverse Opioid Outcomes with Proactive Precision Care

PROJECT SUMMARY FOR PREDICATE STTR PHASE I GRANT
Perioperative and prescribed opioids often result in costly and unpredictable adverse effects, including life
threatening respiratory depression and long-term opioid use/misuse in vulnerable patients. The US FDA warns
against the use of codeine and tramadol in children due to postoperative anoxic brain injuries and deaths, and
in nursing mothers due to serious breathing problems and infantile death. There is an urgent and unmet critical
need for proactive risk identification and personalized precision analgesia to improve safety and effectiveness of
opioids in vulnerable populations. Proactive precision medicine, including preoperative genotyping and
personalized analgesia based on scientific evidence; regulatory warnings; CPIC guidelines; cost-effectiveness
and established insurance coverage for genotyping could minimize excess opioid use and harm associated with
the current trial and error, reactive medicine. Using a patent protected innovative multigene combinatorial
pharmacogenetic opioid risk prediction and decision algorithm, in this Phase I STTR application, OpalGenix, Inc.
proposes to validate the genetic signatures of adverse opioid outcomes in nursing mothers and their babies after
cesarean deliveries. OpalGenix team will partner with academic researchers and leverage nonoverlapping NIH
R01 funding (HD089458 and HD096800) to complement this STTR application to pursue the following two aims:
1) Validate and identify genetic risk factors associated with postoperative opioid adverse effects in adult women
undergoing cesarean section and their breastfed neonates, and 2) Develop an insurer reimbursed multi-gene
laboratory-developed test (LDT) for preoperative genetic risk prediction and decision support for pediatric and
adult surgical patients to prevent adverse opioid outcomes. OpalGenix will develop a minimum viable product
(MVP), a refined multi-gene panel in a CLIA certified laboratory with a robust combinatorial pharmacogenetic
prediction and decision support to personalize surgical analgesia algorithm with precise opioid use in children
and adults. This is expected to prevent common opioid adverse outcomes, such as vomiting and rare life
threatening and compromising outcomes like respiratory depression, chronic persistent surgical pain (CPSP),
opioid dependence, and opioid use disorder (OUD) in vulnerable pediatric and adult surgical cohorts. A future
Phase II STTR will focus on the FDA pre-approval for a CLIA LDT to identify patients genetically pre-disposed
to significant adverse opioid outcomes including overdose, OUD, and Neonatal Opioid Withdrawal Syndome
(NOWS). Based on the current opioid epidemic and projected $2.15 trillion economic burden of opioids between
2020 and 2040 in the US alone, a significant commercial market exists for OpalGenix to proactively identify and
effectively reduce postoperative opioid-related adverse effects, CPSP, OUD, NOWS, and overdose while
maximizing surgical pain relief in millions of Americans each year.

Public health relevance
PROJECT NARRATIVE FOR PREDICATE STTR PHASE I GRANT Opioids are among the most widely used and prescribed analgesics for children undergoing surgery and post- cesarean surgical pain in nursing mothers, resulting in increased and unpredictable opioid-related adverse outcomes, including respiratory depression and death in neonates, children, and nursing mothers. Patent protected, innovative, cost-effective, clinically adaptable and commercially viable technology of OpalGenix has significant public health relevance because it would improve safety and efficacy of opioids in vulnerable populations by proactively identifying patients at risk for opioid-related serious adverse effects, and enabling personalized opioid use with precision dosing.